WA 06, AKT PK/PD Analytical Support (MK2206)

This work involves the analysis of plasma and tumor samples from mouse xenograft studies run at NCI Frederick for MK2206, an oncology drug currently in clinical trials.